Histopathology and Stone Analysis

Project Summary Core B will conduct all the morphological and pathology analyses for Projects 1, 2, and 3. Papillary scoring is an essential part of the PPG, and Core B will analyze all surgical recordings from Projects 1 and 2 to quantify plaque and plug areas on all papillae and to ensure that papillary scoring across the projects is consistent. Human tissues will be collected by Project 2 from carefully categorized stone patients, and Core B will perform light and electron microscopy (LM and EM) using specialized stains on the biopsy material, and using micro- infrared spectroscopy (FT-IR) and Raman methods to identify mineral in the tissue. Core B will also prepare the frozen sections to be used by Project 3 for laser micro-dissection, along with immunostained sections to verify the biopsy content. All stones collected in Projects 1 and 2 will be analyzed by micro CT and conventional FT-IR to provide detailed information on stone type and percent mineral content. Core B will also perform atomic absorption spectrophotometric analysis of lithium to determine distal delivery of solutes in study patients (Project 1), and of calcium in tissue specimens (Project 3).

Public health relevance
Project Narrative Our long-term goal is to discover the mechanisms underlying different forms of kidney stone disease, so that effective treatments can be developed for this common but pathologically diverse condition.